A chatbot-powered G8 screening intervention to facilitate referrals to a comprehensive geriatric assessment among older adults with cancer

The majority of cancer diagnoses and morbidity occurs in patients age 65 and over. This age group has
increased incidence of by
multiple co-morbid conditions, geriatric syndromes, dependence in instrumental
activities and activities of daily living, and polypharmacy reflecting the heterogeneity of aging and influence the
treatment outcomes for older adults. Clinical guidelines recommend the routine use of a Comprehensive
Geriatric Assessment (CGA) for older cancer patients with the potentials to identify and optimize nononcologic
issues and alter chemotherapy decision and improve treatment tolerance. However, a CGA is time intensive
and it is not feasible for every older adult with cancer to be seen by a geriatrician given the shortage of
geriatricians. G8, an eight-item questionnaire, has been recommended as a brief screening tool which is
usually administered by a health care provider with good sensitivity to identify patients who are most likely to
be benefit from a CGA. However, the implementation of the G8 in routine oncology clinical practice has mixed
results with sub optimal uptake due to clinical and system barriers. To fill the void, we propose using a patient-
mediated implementation approach, specifically adopting the Chatbot technology to delivering a structured set
of G8 screening questions that can simulate the content experienced by real-life conversation such as with a
health care provider. Our proposed Chatbot application, JeffSeniorChat, will facilitate G8 screening with
supportive and educational content to explain the purpose and benefit of the G8 tool, each question with
examples and probes to help with recall, and next steps after the G8 assessment is completed and how the
results might impact their cancer treatments. Guided by the Health Belief Model, health communication best
practices and our preliminary formative work, JeffSeniorChat will be iteratively developed and refined through a
rapid prototyping process using patient-stakeholder inputs and plain-language evidence-based content and
usability testing to finalize the intervention. We will examine the feasibility and acceptability of the
JeffSeniorChat intervention targeting G8 self-assessment completion and CGA attendance in 150 older adult
with cancer. Overall G8 score will be automatically calculated by the JeffSeniorChat backend algorithm and
patients with G8 scores ≤ 14 will be prompted to schedule a CGA at Jefferson’s Senior Adult Oncology Center.
Feasibility will be determined by pre-specified enrollment and G8 completion rate. Acceptability will be
measured by participant reported intervention credibility and satisfaction. Among patients with G8 scores ≤ 14
referred to a CGA, exploratory outcomes will examine CGA attendance compliance, predictive value of the
JeffSeniorChat collected G8 score with the final frailty designation determined by the CGA, and perceived
barriers among CGA non-adherent patients via follow-up interviews. Streamlining G8-triage process to a CGA
through the Chatbot-enabled patient self-reported assessment and intervention should improve clinical
efficiency and improve CGA attendance rate, ultimately optimizing treatment selection and outcomes.

Public health relevance
Narrative To address the barriers to implementation of the G8 screener which has been used to screen older cancer patients most likely to benefit from a Comprehensive Geriatric Assessment (CGA), among those barriers is the prioritizing other tasks by the healthcare team given the busy clinical workflow and competing task requirements. The proposed study, adopting an innovative and proactive digital health approach, is to develop and pilot “JeffSeniorChat”, a Chatbot application designed to streamline the G8-triage process to facilitate CGA referrals and improve CGA attendance rate, ultimately leading to the identification and the optimization of non- oncologic issues, alter treatment decisions and improve treatment outcome.